DC-HIL in cancer

PROJECT SUMMARY
Melanoma is a significant cause of morbidity and mortality in the U.S. and among
military veterans. Having discovered an immune-vascular regulating pathway (DC-
HIL/SD4) whose function can be manipulated to treat cancers, we will: (1) dissect its
effects on immunity and vascularity in melanoma; (2) develop treatment targeted at a
key carbohydrate component of the pathway; and (3) characterize changes in this
component during melanoma growth and metastasis. Our results will improve current
management of metastatic melanoma and potentially other cancers.

Public health relevance
PROJECT NARRATIVE Melanoma is an important cause of morbidity and mortality in the U.S. and among military veterans. Immune treatments have prolonged survival of many patients with metastatic melanoma, but resistance to this modality remains high. We discovered: (1) novel pathway (DC-HIL/SD4) that suppresses T-cell immunity; (2) soluble form of DC- HIL that binds to syndecan-4 (SD4) on endothelial cells leading to angiogenesis while inhibiting extravasation of T cells; and (3) precise DC-HIL ligand in SD-4 that is a rare highly-sulfated 8-oligosaccharide (rHS), whose infusion into melanoma-bearing mice reduced tumor growth and expression of angiogenic factors within the tumor. Our proposal will: delineate consequences of DC-HIL and rHS interaction on immunosuppression vs. angiogenesis in melanoma; develop rHS-targeted treatment for melanoma; and characterize expression of rHS during melanoma progression and metastasis.